The Mechanistic Impact of Paternal Electronic Nicotine Delivery Systems Exposure on Thrombogenesis

While the contribution of exposure of future fathers (paternal) to environmental factors, such as smoking, to the
pathogenesis of several disease states has been documented, that of Electronic Nicotine Delivery Systems
(ENDS), including in the context of occlusive cardiovascular disease (CVD), has not yet been investigated.
Therefore, the present application proposes experiments that address fundamental, mechanistic, and clinically
relevant translational aspects of the adverse-health effects of ENDS, namely e-waterpipes and e-cigarettes,
which are increasingly popular forms of tobacco, in the context of paternal exposure on thrombotic disease and
platelet biology. These studies will be performed in a sex-dependent fashion. Specifically, the ramifications of
ENDS paternal exposure on normal hemostasis and the development of thrombosis disease will be determined.
Subsequent studies will examine whether ENDS modulate platelet function and/or counts. Experiments are also
designed to determine the effects of ENDS on the coagulation system and clotting/thrombosis markers. In
addition, and in terms of the mechanistic experiments, the role of the platelet transcriptome (e.g., miRnome) of
the offspring and the epigenetic marks (e.g., histone modification) of the father’s sperm in mediating ENDS
paternal effects will be determined. We will also examine if the development of a proinflammatory and oxidative
stress “state” is involved in the observed phenotype. Finally, the impact of paternal ENDS on the placenta will
also be investigated. Collectively, these experiments will make significant contributions to the understanding of
the consequences of paternal ENDS exposure- an increasingly popular and underappreciated health threat- on
cardiovascular health, as well as the mechanism by which it exerts these effects, in a sex-specific manner.

Public health relevance
Collectively, the experiments presented in this application, some of which are translational in nature, address fundamental, epigenetic and mechanistic concerns regarding the cardiovascular health effects of paternal exposure to Electronic Nicotine Delivery Systems (ENDS), an increasingly popular forms of tobacco, namely e-waterpipes and e-cigarettes, by employing a systematic platelet function and related animal model and disease analysis approach. Results obtained from these studies should promote further “smoking”/tobacco product cessation, as well as lay down the foundation for understanding, and advancing policy and means for evidence-based therapeutic management, prevention and control efforts of tobacco-associated thrombosis-based disease states.